Translational Surgical Pathology

All the goals of the TSP section have been met in these past years since we performed clinical research and collaborated with many investigators in the NCI, CCR and through the NIH, that resulted in many publications, abstracts and presentations. I trained and taught residents, visiting fellows, and lectured at other institutions locally and internationally. I was one of the members organizers of the International Society of Pathology,and organized and gave lectures in the field of GU pathology. Our work with exosomes has been extraordinarily well received.